Administrative Core

The Administrative Core of the Washington University Center for Diabetes Translation Research (WU-CDTR) will continue to successfully provide leadership in setting the overall scientific direction of the Center guided by our strategic vision in which health is the foundation for transformative diabetes research translated into action and impact. Our Center mission is to be the nexus for transdisciplinary team science in advancing the conduct of the next generation of diabetes translation research, and our goal is to build a rigorous, scientific evidence base to inform dissemination, implementation, and sustainability of efficacious interventions for populations at risk for diabetes. The Administrative Core of the WU-CDTR builds on its success to provide the structure for effective and efficient operation and maintenance of the WU-CDTR in compliance with NIH and University guidelines. The Administrative Core coordinates and integrates all activities of the WU-CDTR to help ensure approaches for enhancing successful achievement of the Center vision, mission, and goals. The WU-CDTR Director and Associate Directors, with governance and input from the Executive Committee, are responsible for establishing the goals and direction of the Center, coordinating committee meetings, managing the fiscal aspects of the Center, monitoring and documenting the use of each Translational Research Core, preventing overlap in funding for services provided, managing the Pilot and Feasibility Program, tracking publications that were facilitated by Center Cores, overseeing the Enrichment Program, and reporting annually to the NIH/NIDDK. The Administrative Core ensures the WU-CDTR is well- positioned as a resource for transdisciplinary team science, working to attract and retain early stage and senior investigators in diabetes translation research through its location at Washington University in St. Louis, its regional affiliation with the University of Missouri, and its national affiliation with Parents as Teachers National Center in St. Louis, MO.